PHARMACOLOGY OF THE HIV VIRAL DNA

In an effort to further extend the number of targets for development of antiretroviral agents, we are investigating potential HIV integrase inhibitors using in vitro integrase assays. The active compounds are submitted for testing antiviral activity in the Anti-HIV Drug Screen. Conversely, we are testing active compounds from the screen for HIV integrase inhibition. The molecular interactions of the drugs with the HIV integrase are investigated by comparing the drug effects using several assays exploring different steps of the integration reaction: l) DNA binding 2) dinucleotide cleavage (3'-processing), 3) nucleophilic attack by the cleaved DNA (integration by strand transfer), 4) dis-integration (reverse of the integration reaction) by wild-type and truncated HIV-l integrases. We are also investigating the role of topoisomerases in integration and transcription. Our goals are to discover new antiviral agents, to determine whether drug screening of active agents will lead to the discovery of integrase inhibitors, and to evaluate which step of the integration reaction can be inhibited by drugs (enzyme oligomerization, DNA binding, 3'-processing, DNA strand transfer, disintegration). In order to test the hypothesis that some of the inhibitors may interfere with functional domain of the enzyme (zinc finger, catalytic region, DNA binding domain), genetically altered HIV-l integrases are used. Discovery of new HIV integrase inhibitors may provide new strategies for antiretroviral therapy and basic knowledge for drug-enzyme interactions.